Understanding the Genetic Contributions to Variation in Ozone Exposure Response

PROJECT SUMMARY
Ozone is a common ambient air pollutant that presents a significant public health hazard as a trigger for lung
function decrements, airway inflammation, and exacerbations of asthma and COPD symptoms. Controlled
human exposure studies have found that the severity of these responses varies widely across individuals while
the severity of a given individual’s reaction is reproducible across multiple independent exposures, indicating a
potential genetic contribution to one’s risk for a severe response. Results from animal models also indicate that
response to ozone is a complex trait. The genetic variants that underly this variation are currently unknown and
this data gap needs to be addressed to identify high-risk individuals. Mapping expression quantitative trait loci
(eQTL), which are statistical associations between variants and gene expression, is one approach used by
human geneticists to study the genetic basis of complex traits. However, most eQTL mapping studies have used
unperturbed/unexposed samples which may miss eQTL that only manifest after exposure or have an altered
magnitude of effect with exposure, termed “response eQTL.” These response eQTL are thus gene-by-
environment interactions. Studying these interactions in humans is often difficult, making in vitro models an
attractive approach. Primary human bronchial epithelial cells (HBECs) isolated from the airway are a highly
relevant in vitro model. HBECs can be readily cultured into a well-differentiated pseudo-stratified epithelium
similar to that found in vivo and are cultured at an air-liquid interface, enabling in vitro exposures which mimic in
vivo exposures. Additionally, using primary cells from different donors provides the genetic variation necessary
for mapping eQTL. The goal of my project is to use this in vitro model to identify ozone response eQTL, genome-
wide, and identify overlapping signals with asthma and COPD GWAS loci. I hypothesize that mapping ozone
response eQTL in a physiologically relevant cell culture model will identify variants associated with response
variability. Further, I hypothesize that some of these response eQTL will colocalize with GWAS signals for asthma
and COPD, which have both been shown to be affected by air pollution exposure. In Aim 1, I will characterize
the transcriptomic response to ozone in HBECs from 202 donors with diversity in age, sex, genetic ancestry, and
smoking history. In Aim 2, I will map baseline and ozone response eQTL, using the difference in gene expression
between filtered air and ozone exposed culture pairs from each donor to map response eQTL. In Aim 3 I will
perform colocalization between ozone response eQTL and GWAS for asthma and COPD, followed by Mendelian
randomization analysis to evaluate a signal’s effect on disease via gene expression. In total, I will identify genetic
drivers of increased risk for severe response to ozone using a response eQTL strategy to find context-dependent
eQTL, which will improve identification of susceptible individuals and inform policy regarding safe levels of
exposure.

Public health relevance
PROJECT NARRATIVE Ozone is a common ambient air pollutant that causes pulmonary inflammation and decreased lung function upon acute exposure and is further associated with chronic respiratory diseases including asthma and COPD. There is ample evidence of interindividual variation in response to ozone in humans, but the genetic contribution to this variation is largely unknown. This study will use an in vitro model of the human lung featuring genetic diversity to identify risk variants for severe response to acute ozone exposure, then assess their overlap with asthma and COPD risk variants, which will guide identification of high-risk individuals.